Mechanisms of regulated translation control in cancer and its therapeutic implications

PROJECT ABSTRACT:
Oncogenes and tumor suppressors directly highjack the cell’s translation apparatus to make their own tailored
proteome to direct specific steps in cancer development. This is molecularly achieved through translationally
regulated nodes of gene expression that can direct cancer initiation and progression. My lab has been at the
forefront of this research by generating modern tools and developing the first genetic loss- and gain-of-function
mouse models for distinct components of the translation machinery which, in combination with new
quantitative measures of the translational landscape of gene regulation, have led to a fundamental change in
our understanding regarding the molecular origins of cancer. In this proposal, we will leverage and extend our
long-standing interests in translational control in cancer to address three major goals, as follows: 1) What are
the synthetic lethal interactions targeting the aberrant translation control program in cancer? Here, we will
characterize a series of novel synthetic lethal genetic interactions with the major cap-binding protein eIF4E
that we have discovered specific to cancer cells. For example, we will elucidate a surprising genetic interaction
between translational control and splicing as well as translation and mitochondrial proteostasis. We will
translate these findings to in-vivo mouse models as well as xenografts and patient-derived xenografts to define
the importance of such synthetic lethal interactions in human cancers and target them by employing new
selective compounds that block eIF4E hyperactivation in human cancers. 2) How is translation control linked
to metabolic programs in cancer cells? As nutrient abundance drives anabolic processes, such as protein
synthesis, we will determine how translation control influences metabolic homeostasis linked to diet and the
cellular environment in cancer. We will assess the functional consequences of genetically and
pharmacologically modulating eIF4E activity in cancers associated with obesity and employ unbiased profiling
methods to delineate the impact of eIF4E on metabolic signaling that circulates in the blood stream. 3) What
are the mechanisms by which oncogenes direct the formation of “cancer ribosomes”? A fundamentally
unanswered question is whether the presence of distinct ‘cancer ribosomes’ may drive translation of the
cancer genome to direct specific steps in cancer development. We will establish the first systematic, and
large-scale characterization of ribosome composition and study its genome-wide impact on gene regulation
during distinct phases in Myc-induced tumor development. Importantly, changes in ribosome composition may
offer a completely new therapeutic pipeline to selectively inhibit human ribosomes that translate specific,
cancer-causing mRNAs.

Public health relevance
PROJECT NARRATIVE: Alterations in translation control is a “hallmark” of cancer. The PI has consistently made highly impactful contributions to our understanding of how oncogenic pathways highjack the cell’s translation apparatus to make their own tailored proteome to direct specific steps in cancer initiation and progression. The project described in this application will employ novel pharmacogenomics approaches to address major unanswered questions in the field of translation and cancer, providing the rationale and tools for a new paradigm to target human tumors.